Hypoxia, Genetic Instability and DNA Mismatch Repair

DESCRIPTION (provided by applicant): Genetic instability is a hallmark of cancer. We have discovered that the hypoxic tumor microenvironment is an important cause of this instability. We have determined that hypoxic stress causes decreased expression at the transcriptional level of the DNA mismatch repair (MMR) factors, MLH1 and MSH2, and of the homology- dependent repair (HDR) factors, RAD51 and BRCA1. The MMR and HDR pathways are critical for maintaining genomic integrity. They play important roles in repairing environmental and endogenous DNA damage, and they influence the response of tumor cells to many cancer therapies, including ionizing radiation and alkylating and cross-linking agents. Mutations in MLH1 and MSH2 have been linked to hereditary colon cancer, while mutations in BRCA1 are associated with hereditary breast and ovarian cancers. In addition, MLH1 and BRCA1 levels are reduced in many sporadic cancers of these and other sites, a process associated with epigenetic silencing. Mechanistically, our initial studies have linked the Myc/Max network of transcription factors to the regulation of MLH1 and MSH2 expression and the E2F family of factors to the regulation of BRCA1 and RAD51. In this competing renewal application, we propose hypothesis-driven, mechanistic studies to elucidate the stress- response pathways that modulate the expression of these MMR and HDR repair genes. Using a battery of genetic and biochemical techniques, our work will focus on transcriptional regulation, epigenetic chromatin modification, and signal transduction events that occur in response to hypoxia and that may regulate DNA repair. We will also test specific hypotheses regarding the influence of hypoxia-induced changes in DNA repair on DNA damage signaling and on the efficacy of tailored therapeutic strategies that exploit these DNA repair changes. The altered regulation of DNA repair in response to cellular stresses such as hypoxia may be a key cause of genetic instability that promotes carcinogenesis and fosters tumor progression. At the same time, it may also offer the possibility of devising therapeutic strategies to which hypoxic cancer cells, but not normoxic, non- malignant cells, are especially susceptible. Hence, the proposed work will contribute to our understanding of basic cancer biology and may provide the basis for new approaches to cancer therapy.